Research Resource for Human Organs and Tissues

The Human Tissue and Organ Research Resource (HTORR) is a division of the National Disease Research Interchange (NDRI), a not-for-profit NIH-funded organization whose mission is to provide the biomedical research community with human tissues for research. The requirements for human biospecimens continue to evolve in tandem with complexity of scientific questions and experimental methodologies that investigators desire to pursue. To meet this requirement, HTORR utilizes a project-specific approach and a substantial network of tissue source sites (TSS) to provide investigators with the opportunity to obtain a broad range of normal and diseased human biospecimens for their studies. HTORR’s expertise involves a five-pronged approach to creating a reliable research resource to meet this emergent need for investigators. HTORR provides: 1) expert customer service and 24/7 support for investigators, 2) a solution-oriented approach for investigators via the opportunity to develop project-specific protocols for each project, 3) access to human biospecimens from all body systems, 4) ongoing outreach efforts via multiple platforms to increase awareness of the resource, and 5) industry best practices and standards regarding the donation of human tissue for research. Implementation of this plan will ensure uninterrupted service of high quality, well annotated normal and diseased human biospecimens to investigators from an established network of tissue source sites, in concert with the development and implementation of innovative, large scale initiatives for the biomedical research community.

Public health relevance
Program Director/Principal Investigator (Bell, Thomas, J): Project Narrative The research demand for human tissues continues to grow and the HTORR program provides a unique service to biomedical investigators nationwide whose research requires human tissues, organs and well annotated data. Over the past 4 years, nearly 500 scientific papers were published by scientists who used HTORR-provided tissues, confirming HTORR's indispensable contribution to the biomedical research community and the impact of these services on the search for new treatments and cures for common and rare diseases, including HIV/AIDS. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page